UCSF-Kaiser Urological Epidemiology Research Career Development Program

PROJECT SUMMARY
Overview and Structure: The University of California San Francisco-Kaiser Permanente Northern California
Urological Epidemiology (UCSF-KPNC UroEpi) K12 Program provides rigorous training, multidisciplinary
mentoring, and career support to junior faculty developing high-impact epidemiological research programs in
non-malignant urological conditions. Our institutions will continue to collaborate successfully to provide faculty
with the mentoring, skills, and experience they need to achieve success as epidemiologic investigators.
Scholars will continue to be based at UCSF and the KPNC Division of Research, both with robust scientific
infrastructures, where they will be able to access an unparalleled set of data resources, including data from the
entire KPNC patient population. The history of collaboration between our institutions and Program Directors will
perpetuate our superb track record of developing future leaders in urological epidemiology.
Training and Pipeline: This highly structured program includes comprehensive mentoring, rigorous didactic
training, career development activities, and hands-on research. Each Scholar benefits from an individually-
tailored, multidisciplinary training program, with available programs including a certificate program, masters or
PhD degree program in research methods and/or epidemiology, mentored work-in-progress and career
development seminar series, and diverse specialized courses. We have also identified over a dozen Research
Program Areas in non-malignant urology that leverage the UCSF-KPNC environments' diversity, direct access
to real-life clinicians and patients, and mentors' methodological and content area strengths. With UCSF's
diverse array of training programs, including multiple earlier-stage research training programs directed at the
resident and postgraduate fellow level, we have an excellent pipeline of future, diverse K12 scholar candidates.
Program Progress: Since this program was launched less than four years ago, it has already been successful
in identifying exceptional Scholars from diverse backgrounds and guiding them to success in epidemiology
research. Our past and current UCSF Scholars have not only been productive in publications and research
accolades, but have also competed successfully for NIH funding. Along with our recently appointed and
pending Scholars, they also contribute to diverse perspectives in urological epidemiology research.
Innovation and Impact: This program's innovative pairing of a top tier academic center with a learning and
integrated health care system represents an excellent investment of NIDDK resources to catalyze the growth
of urological epidemiology research in a uniquely fertile environment. We will continue to build upon our long
history of collaborative, multidisciplinary research that complements other large projects supported by NIDDK,
such as O'Brien, MAPP, and LURN Centers. Thus, our environment enables our UroEpi Scholars and their
mentors to make unique research discoveries with important implications for clinical practice and public health.

Public health relevance
PROJECT NARRATIVE In this career development program, the University of California, San Francisco (UCSF) and Kaiser Permanente Northern California (KPNC) will provide rigorous interdisciplinary training and robust career development support to junior faculty developing research programs in urological epidemiology. Our leadership and faculty at UCSF and KPNC have a superb track record of producing accomplished, independent scientists in urology, epidemiology, and related fields. This program will leverage the unique environment of KPNC, a large learning health care system with a diverse population and extensive electronic clinical data, numerous prospective cohorts, and the rich investigative and educational resources of UCSF to develop emerging leaders in epidemiology of non-malignant urology conditions.